Multi-ethnic Observational Study in American Asian and Pacific Islander Communities (MOSAAIC) Mental Health Administrative Supplement

Project Summary
The Multiethnic Observational Study in American Asian and Pacific Islander Communities (MOSAAIC) is a
groundbreaking study focused on understanding cardiometabolic and mental health disparities in Asian
Americans, Native Hawaiians, and Pacific Islanders. By enrolling 10,000 participants, the study aims to
uncover risk factors and improve health outcomes. We collect extensive data through clinical exams, biological
samples, and annual follow-ups. We propose this administrative supplement to enhance the rigor of the
MOSAAIC cohort study’s research relating to the burden of mental health conditions among Asian and Pacific
Islander communities and the relationship of mental health with cardiovascular disease risk. The goals of the
administrative supplement are to assess the psychometric properties of standardized mental health survey
instruments when administered in five Asian languages and to develop protocols to address suicidal ideation,
especially in underserved communities. These protocols will be culturally and geographically tailored to ensure
appropriate responses across diverse field centers.
To achieve these aims, the study will rigorously evaluate mental health instruments' psychometric properties
and ensure their accuracy and cultural relevance. The study will also adapt mental health tools for non-English-
speaking populations. The development of the suicidal ideation protocol will involve collaboration with experts
in psychiatry and psychology to ensure culturally sensitive crisis management training.
This approach strengthens the scientific integrity and ethical standards of the parent MOSAAIC study by
enhancing participant safety, wellbeing, and data quality. The proposed enhancements will also contribute to
the long-term goals of informing health policies and improving health interventions for these historically
underrepresented communities. The project aligns with the parent grant’s objectives, advancing the research
capacity needed to address significant health disparities.

Public health relevance
Project Narrative The Multiethnic Observational Study in American Asian and Pacific Islander Communities (MOSAAIC) is a groundbreaking effort to address cardiometabolic and mental health disparities among underrepresented populations through rigorous, culturally tailored research. With a focus on inclusive methodologies, MOSAAIC translates widely used mental health instruments into five Asian languages, evaluates their psychometric properties, and strengthens participant safety by implementing a comprehensive suicidal ideation safety plan. These efforts ensure ethical, culturally sensitive data collection while prioritizing the well-being of participants as well as study staff.